Clinical Research Center for the Improved Prevention, Diagnosis, and Treatment of Vocal Hyperfunction

Project Summary/Abstract
Vocal hyperfunction (VH) is associated with the most frequently occurring types of voice disorders. These include
benign vocal folds lesions (e.g., nodules and polyps) and dysphonia that occurs in the absence of concurrent
pathology (e.g., muscle tension dysphonia). Effective prevention and clinical management of these disorders
continue to be hampered by limited knowledge of the etiological and pathophysiological mechanisms that
underlie specific voice disorders within the broad range of those associated with VH. To address this need, this
Clinical Research Center brings together a multidisciplinary team of experienced investigators to pursue a
comprehensive program of research focused on hyperfunctional voice disorders. The central theme of the Center
is that the clinical management of hyperfunctional voice disorders can be significantly improved by attaining a
better understanding of the etiology and pathophysiology of these disorders and then translating this knowledge
into new, more effective methods for prevention, diagnosis, and treatment.
A central premise of this work is that multiple factors contribute and interact in different ways to cause and
maintain the various disorders linked to VH. The most important are associated with behavioral, sensorimotor,
environmental, psychological/emotional, physiological, and biomechanical mechanisms. The interdisciplinary
research program will focus on attaining a comprehensive understanding of the fundamental relationships
between these factors and the different manifestations of VH. Research at the Center is guided and coordinated
by a comprehensive theoretical framework for VH that clearly illustrates the key hypotheses that will be assessed
in a coordinated effort overseen by an Administrative Core and carried out by the four Research Projects and
Technology and Data Science Core. Projects will employ an innovative combination of laboratory studies of
sensorimotor and physiological mechanisms; physical and computational modeling of biomechanical, aero-
acoustic, and auditory-motor control mechanisms; and the use of improved ambulatory voice monitoring
technology to investigate potential etiological and pathophysiological mechanisms of VH associated with daily
voice use. A clinical trial will also assess the benefit of combining novel ambulatory biofeedback with evidence-
based voice therapy to treat VH. A significant strength of the Center will be a centralized multidimensional
database in the Technology and Data Science Core that receives comprehensive data from all of the projects
for all enrolled patients and healthy controls, thus greatly facilitating the integration of results across the projects
and magnifying the impact of the Center well beyond the sum of its parts.
This program of research in hyperfunctional voice disorders is unprecedented in terms of its scope, integration
of information across multiple domains, number of innovative concepts, and methods that are being
simultaneously developed and tested. Achieving the goals of this research program will significantly improve the
prevention and clinical management of these highly prevalent disorders.

Public health relevance
Project Narrative Although vocal hyperfunction is linked to the most prevalent types of voice disorders, effective prevention and clinical management of these disorders continue to be hampered by limited knowledge of underlying etiological and pathophysiological mechanisms. To address this need, this Clinical Research Center brings together a multidisciplinary team of experienced investigators to pursue a comprehensive program of research focused on hyperfunctional voice disorders. Achieving the goals of this research program will lead to improved prevention, differential diagnosis, and more focused and efficient treatment of these highly prevalent conditions.